Administrative Core

ADMINISTRATIVE CORE SUMMARY/ABSTRACT
The Administrative Core will assume overall responsibility for program coordination, communication with
outside entities, and fiscal management. The core will be led by the PI, Dr. David Erle, who has substantial
experience with leading large NIH-funded multi-investigator programs. The Administrative Core will coordinate
activities of the two projects and the Clinical Subjects and Biospecimens Core to ensure that critical information
and biospecimens are shared efficiently. The core will arrange monthly AADCRC conferences and meetings
with the internal advisory committee and external advisors. The PI will participate in monthly conference calls
with NIAID staff and leaders of other AADCRCs, and will work with other program personnel to ensure we are
well-represented at the annual AADCRC meetings in Bethesda. The PI will work closely with an experienced
administrative staff member to ensure that AADCRC funds are spent wisely and according to all applicable NIH
regulations.